A Pragmatic Trial of Integrating Community-based Patient Navigation into the Continuum of Maternal Care for Black Women in a Safety-Net Health System: Effects on Maternal Health, Health Care, Morbidit

ABSTRACT
US maternal mortality is substantially higher than that of other developed nations, with Georgia ranking second
highest among the states. Maternal mortality and severe maternal morbidity (SMM) are increasing in Georgia,
with the highest rates among those who are Black, publicly insured or uninsured, and deliver in safety-net
hospitals. Maternal morbidity and mortality occur on a continuum in which the accumulation and progression in
severity of events can be prevented through access to and utilization of quality health care. Georgia’s Maternal
Mortality Review Committee concludes that two-thirds of maternal deaths are preventable and attributes recent
increases to rising rates of inadequately managed chronic health conditions, mental health disorders,
substance use, and pregnancy complications in the setting of care that is often difficult to access, fragmented
and of insufficient quality. Experts emphasize that equity-centered health care approaches – which embed
transformational aspects into their design through stakeholder input and Black-led models of care that include
social support to counter stress related to racism and weathering – offer the most promise for reducing
inequities. Emerging data support that the incorporation of racially-concordant, community-based patient
navigators can enhance the cultural-competence of care while addressing discrimination, systemic racism, and
institutional barriers to quality care. To date, however, limited research has evaluated this promising strategy in
real-life settings using rigorous methods with sufficient sample size and ascertainment of morbidity and
mortality endpoints critical for determining effectiveness and motivating large-scale policy and practice change.
We posit that the integration of community-based patient navigators into maternal care will improve maternal
health outcomes through meeting social needs, lowering stress and depressive symptoms, and improving
access to and utilization of care thereby promoting better and more timely management of conditions and
reducing the occurrence and progression of complications. To test this hypothesis, we propose to perform a
pragmatic randomized controlled trial (RCT) of the integration of community-based patient navigators into the
continuum of maternal care, starting prior to mid-pregnancy and continuing through one-year of birth, among
500 Black women with identified health and social needs in a safety-net hospital system to include both
outcome evaluation, to discern effectiveness in reducing maternal morbidity and mortality, and process
evaluation, to enhance understanding of RCT findings. We will employ the Respectful Maternity Care and the
NIMHD Research Frameworks to rigorously evaluate maternal health outcomes in a hospital system that
primarily serves Black women with high unmet needs who experience excessive rates of adverse maternal
health outcomes via a multi-disciplinary team experienced in health services and community-based research,
equity-centered care, and with the capacity to implement a care model intervention with high fidelity and
acquire and utilize health system and patient-reported data to conduct comprehensive, high-quality evaluation.

Public health relevance
Project Narrative In Georgia, racial disparities in adverse maternal health outcomes, including severe maternal morbidity and maternal mortality, are wide and persistent. Equity-centered, transformational models of care offer promise for reducing these disparities and achieving maternal health equity, however, data sufficient for supporting the adoption of such models into health care practice are lacking. To fill this critical gap, we propose to complete an outcome and process evaluation within a pragmatic randomized controlled trial (RCT) of the integration of community-based patient navigators into the continuum of maternal care of Black women in a safety-net hospital system in metropolitan Atlanta, Georgia.